JEOL CRYO ARM 200 Microscope with Direct Electron Apollo detector

Abstract
Funds are requested toward the purchase of a JEOL CRYO ARM 200 microscope with Direct Electron Apollo
detector. The University of Utah and regional partners Brigham Young University and Utah State University have
a large, vibrant, and well-funded community of structural biologists with well-established and emerging research
programs that depend upon cryo-electron microscopy (cryo-EM). This community includes 13 Major Users and
11 Minor Users, supported by 35 NIH awards, who would use the new instrument. Multiple additional user grants
will also directly depend upon access to the new instrument, including from NSF and private foundations. Our
community already makes extensive use of the University of Utah Core Facility in Electron Microscopy, which is
supported by a faculty-level Director and a faculty-level Director of Cryo-EM, both of whom have extensive
experience in the instrumentation, methods, and applications of cryo-EM. The EM core facility currently houses
just one instrument that is suitable for single-particle high-resolution cryo-EM, a ThermoFisher Scientific Titan
Krios with a Gatan K3 detector. This instrument is state-of-the-art but is fully utilized and is experiencing a
dramatic reduction in availability for single particle cryo-EM owing to commitments to the agency (Beckman
Foundation) that funded purchase of both the Krios and a recently installed ThermoFisher Aquilos 2 Cryo-FIB.
Specifically, the Beckman funding required that 50% of the Krios time be available to support cryo-electron
tomography (cryo-ET) of samples generated using the Aquilos. This is appropriate because the Krios is
especially well suited for cryo-ET. Compounding the need for enhanced single particle cryo-EM data collection,
our aging ThermoFisher Tecai F20 instrument, which in principle could be used for screening, has become
outdated, problematic to maintain, and will be retired. Furthermore, our user community is burgeoning with
multiple recent junior recruits, recently recruited and highly active senior faculty members, and with multiple
additional faculty recruitments envisioned. To address these needs, we propose to purchase a JEOL CRYO
ARM 200 microscope with Direct Electron Apollo detector that will be housed in the EM core facility. This is an
optimal solution because the instrument combines highly efficient screening with high-resolution data collection,
is highly cost effective, can be used essentially 24/7, and will be housed, maintained, and managed in an
outstanding existing core facility.

Public health relevance
Narrative The determination of three-dimensional models of macromolecules and complexes by cryo-EM is of central importance for advancing understanding of molecular mechanisms that function in biological pathways. These advances provide understanding of health and disease, and can inform the development of new therapeutics. The University of Utah and partnering regional institutions have a large and highly active community of structural biologists who urgently need enhanced capability for cryo-EM data collection that will be met by the proposed instrumentation.